Duration of Immunity Elicited by Pertussis Vaccines

To advance our scientific understanding of host responses to pertussis infection and vaccination; efforts may help guide the development of novel and improved pertussis vaccines.